Research Training/Education (Core B) p372-383

The primary educational mission of the Vermont Center on Tobacco Regulatory Science (VCTRS) is to develop an exemplary predoctoral and postdoctoral training program in tobacco regulatory science. The training program will be primarily located at the University of Vermont (UVM), but will also include postdoctoral training positions at our collaborating institutions. Brown University and Johns Hopkins University. Consistent with the overarching focus of the VCTRS, this training program will focus on regulatory science related to premarketing studies on the addictiveness and adverse health effects of new tobacco products among vulnerable populations. Training slots at each of the participating sites will be dedicated to tobacco regulatory science, but will be integrated within the already existing and highly-regarded training programs in addictions at these three institutions. Such a model will serve to assure that fellows receive thorough training in regulatory science and addictions research while also creating the opportunity to introduce other fellows within these larger training programs to the fundamentals of tobacco regulatory science.